Reducing oral health disparities in children using predictive analytics and mathematical modeling

Project Summary
Tooth decay is the most common chronic disease among U.S. children.2,3 Despite efforts to increase utilization
among minority populations by improving coverage for dental insurance via Medicaid and Children’s Health
Insurance Program (CHIP), large oral health disparities remain with Black and Hispanic children having the
poorest oral health of any racial groups in the US.5-8 In addition to lack of access to recommended care, individual
health behaviors (e.g., poor dietary and oral hygiene) and community- and provider-related structural factors
also contribute to the high risk of severe dental caries in minority populations.6,9 State Medicaid and CHIP dental
programs are encouraged to consider strategies to reduce oral health disparities in their delivery system
improvement efforts,6 however, they are challenged with improving quality and reducing quality disparities among
high-need beneficiaries in a cost-effective way.6 Steps toward successful program improvements include the
ability to validly measure the value of care (defined by both health outcomes and costs) delivered to their
beneficiaries, as well as incorporating racial/ethnic disparities in the assessment. There is a critical gap in our
understanding of the influence of race/ethnicity and its interaction with multilevel risk factors on disparities in
quality and oral health outcomes. The scientific objective of this research plan is to study multilevel determinants
of oral health and disparities in quality of dental care and assess the value of improving care and eliminating
racial/ethnic disparities in quality. In Aim 1, we will develop a risk prediction model of severe dental caries by
applying machine-learning based survival analysis4,10 on electronic health record (EHR) data to understand the
influence of race/ethnicity on progression of severe caries and explore heterogenous treatment effects of dental
care. In Aim 2, we will analyze individual-level claims in Medicaid Analytic eXtract (MAX) data combined with
multiple data sources to comprehensively measure racial/ethnic disparities in overall quality of dental care, using
evidence-based quality indicators, and identify modifiable structural risk factors creating disparities. In Aim 3,
incorporating results from Aims 1 and 2, a microsimulation model of severe caries, integrating individual-level
data with data on key contextual factors, will be developed and used to assess the cost-effectiveness and value
of improvements in care stemming from dental quality measures and eliminating racial/ethnic disparities in
quality. Findings from this study will support decision-making by policymakers and stakeholders, and will form
the basis of an R01 application to study novel strategies that target underserved and vulnerable populations.
This research plan is complemented by a career development plan that builds on the applicant’s background in
health policy and decision science. Specifically, this career development plan outlines new training in three
areas: (1) oral health epidemiology, (2) health disparities research, and (3) advanced analytics methods. The
combined research and training plan will prepare the applicant for a successful independent research career
identifying, evaluating, and implementing multilevel interventions to reduce racial/ethnic disparities in oral health.

Public health relevance
Project Narrative Despite considerable efforts to reduce oral health disparities, poor oral health continues to disproportionately affect Black and Hispanic children. The proposed research will investigate the influence of race/ethnicity on progression of dental caries and identify modifiable structural risk factors of disparities in quality of dental care to assess the cost-effectiveness and value of dental care, incorporating racial/ethnic disparities in the assessment of value. The results of this project are expected to inform multilevel interventions and support evidence-based policymaking by identifying strategies resulting in high-value care that also address equity.